Relating Structure to Function in Optic Neuropathies

Relating Structure to Function in Optic Neuropathies
Glaucoma is a progressive optic neuropathy, marked by characteristic losses of retinal ganglion cells and
connective tissue remodeling, that leads to irreversible vision loss. The exact etiology and pathophysiology of
the disease remains unclear. Hence, the clinical diagnosis and monitoring are dependent on measures of
intraocular pressure, and an indirect assessment of retinal ganglion cells using in vivo imaging and
assessment of visual function. The current clinical standards for glaucoma evaluation are effective for detecting
and monitoring disease. However, current clinical testing is ineffective for determining an eye’s susceptibility to
disease, and current vision testing does not completely represent functional vision. The lab's long-term goals
are to refine in vivo structure and function measures to determine; 1. An eye's susceptibility to disease, 2. Its
retinal ganglion cell (RGC) content, and 3. Functional changes with RGC damage/loss. This proposal has two
aims, which build on our previous findings and are designed for the non-human primate, which has similar
ocular anatomy and visual function as humans. Relevant to aim 1, we previously reported that the risk of
retinal ganglion cell loss in experimental glaucoma was related to the viscoelastic properties of the neuroretinal
rim tissue, and the extent of axial elongation following chronic pressure elevation. Myopia or nearsightedness
occurs when the optics of the anterior segment focus light from a distant object in front of the retina, and axial
elongation is the main contributing factor. Myopia is an independent risk factor for glaucoma. Further, like
glaucoma, there is significant variability in experimental models of myopia. We hypothesize that accelerated
axial elongation, with form deprivation myopia, results in connective and neural tissue remodeling, as reflected
in pressure challenge experiments, both increasing the risk of ganglion cell loss. In this aim, we will also
determine if eyes with greater axial elongation with form deprivation myopia or their control eyes, are eyes that
develop more severe experimental glaucoma. Relevant to aim 2, we previously reported that the relationship
between visual thresholds, with standard automated perimetry, and retinal ganglion cell content follows that
predicted by spatial summation. Further, data from experimental glaucoma eyes were shifted up and have a
larger critical area. Spatial summation can be modeled to represent the cortical pooling of spatial filters of
specific spatial frequencies. Our preliminary data suggest that there are disease stage-specific losses in spatial
frequency contrast, and that eyes with experimental glaucoma have either non-functional or dysfunctional cells.
We hypothesize that with progressive retinal ganglion cell loss, contrast sensitivity at higher spatial frequencies
is reduced before that at peak contrast, and thresholds for standard size III stimuli. Further, we will test the
hypothesis that eyes that are faster progressors with experimental glaucoma will have increased neural noise,
determined using the equivalent noise paradigm, indicative of dysfunctional retinal ganglion cells.

Public health relevance
Project Narrative Primary open angle glaucoma is a leading cause of vision loss, which has an estimated prevalence of 3.29% in North America, and the number of people with the disease is expected to increase by 20% between 2020 and 2040. In this project we will determine if longer eyes or eyes at risk of accelerated axial elongation, are also at greater risk of glaucoma. Using functional testing, we will also determine if eyes that progress faster also have greater intrinsic noise.